Foundational Training in the Use of the Laboratory Mouse as a Model of Human Disease

PROJECT SUMMARY
The laboratory mouse, the best genetically defined experimental vertebrate model organism for humans,
continues to be the primary animal research model of human disease and is a key tool for the translational
hands-on training required to engage in modern scientific research, veterinary science, and clinical settings.
However, while many institutions provide access to online training modules, few if any have coordinated,
intensive, hands-on training in the laboratory mouse. Moreover, there are unmet needs to lower the barriers to
participation in advantageous training by diverse and disadvantaged learner groups, to provide equitable access
and, in alignment with stated NIH priorities, to train and diversify the biomedical workforce. To help address this,
The Jackson Laboratory (JAX) proposes to provide a traveling workshop, entitled Foundational Training in the
Use of the Laboratory Mouse as a Model of Human Disease, to be held at partner minority-serving institutions
(MSI). This workshop will provide learning and skills development focused on fundamental techniques that are
employed across a wide variety of animal research and animal models of human disease. The proposed Aims
of the workshop are: (1) To deliver foundational, experiential, training in the use of the laboratory mouse that
participants can apply to their research and that will facilitate their career development; and (2) To facilitate
engagement, active learning, and skills development by diverse and disadvantaged learners by partnering with
MSI to bring hands-on workshops and experiential learning to their institutions. Participants completing this
workshop will obtain valuable exposure, perspective, and skills in the use of laboratory mice for biomedical
research and as models of human disease and they will learn techniques that they can apply to their research
and that will facilitate their career development. JAX is uniquely positioned to execute these traveling workshops:
the program will be facilitated by certified and experienced lead instructors from JAX and mobile lab equipment
has already been acquired in order to be able to hold this workshop at any partner institution that has basic lab
space and a vivarium. Indeed, we have successfully piloted this program at a partner MSI, with highly positive
participant feedback. We will offer the proposed program at no cost to the host institutions or to the program
participants, making the workshop incredibly accessible and inclusive.

Public health relevance
PROJECT NARRATIVE The laboratory mouse is the best genetically defined experimental vertebrate model organism for humans and, with widespread use in biomedical research, continues to present a major opportunity for advancement in the understanding of the genetics, biology and interventions of human disease. While many institutions provide ample access to didactic courses, few, if any, have intensive hands-on training in the experimental use of the laboratory mouse. Therefore, we propose to provide a unique opportunity to the next generation of biomedical researchers and health care providers by adapting a highly successful and high-impact workshop that we have thus far offered at The Jackson Laboratory and taking it “on the road” to their home institutions with an explicit focus on reducing barriers to participation by diverse and disadvantaged learner groups.